CHRONIC RENAL FAILURE IN THE HOPKINS PATIENT POPULATIONS

This CLINFO ONLY study collects and analyzes data obtained from many patient populations who are undergoing medical and surgical interventions in the progression of chronic renal failure.